Impact of CRISPR-associated transposons on anti-phage immunity in Vibrio cholerae

PROJECT SUMMARY
Vibrio cholerae is the causative agent of the infectious diarrheal disease, cholera, which affects several million
individuals and causes ~100,000 deaths, annually. It has become increasingly clear in recent years that
horizontal gene transfer events played a crucial role in the explosive diversification of a non-pathogenic strain
from the Middle East into the present-day pathogenic El Tor biotype strain. Virulence and antibiotic resistance
genes are broadly disseminated within marine Vibrio communities by mobile genetic elements (MGEs), including
bacterial viruses, plasmids, and transposons, many of which permanently integrate their genetic payloads into
the genome. Furthermore, dynamic interactions between V. cholerae and viruses directly impact the duration
and severity of cholera outbreaks, and are potently influenced by the complex repertoire of antiviral defense
systems spread by MGEs. Thus, viral predation and viral immunity affect V. cholerae fitness and pathogenicity,
highlighting the need to better understand horizontal gene transfer processes that modulate antiviral defense.
Our laboratory recently discovered a new class of transposable elements that encode nuclease-deficient
CRISPR-Cas systems and spread via RNA-guided DNA integration, representing the first example of a fully
programmable transposase. These CRISPR-transposon (CRISPR-Tn) systems are prevalent in Vibrio species,
and our studies have thus far focused on a representative transposon derived from a clinical V. cholerae isolate
sampled during the 2010 Haiti cholera epidemic. Remarkably, during our recent analyses of the genetic cargos
found within a larger set of CRISPR-transposons, we uncovered a striking enrichment in antiviral defense genes,
suggesting that these MGEs spread horizontally via conjugative plasmids and benefit host cells by mobilizing a
rich complement of innate immune systems. Our central vision is to determine how V. cholerae immunity and
pathogenicity is influenced by the acquisition of CRISPR-Tn cargo genes, while also developing RNA-guided
transposases as a new tool for kilobase-scale genome engineering in V. cholerae. In Aim 1, we will employ
bioinformatics, genetics, and high-throughput sequencing to comprehensively investigate the evolutionary and
mechanistic diversity of CRISPR-Tn systems, and leverage the most active systems for high-efficiency genomic
insertions and deletions in V. cholerae. In Aim 2, we will analyze the complete repertoire of CRISPR-Tn cargo
genes and determine which gene clusters provide protection against Vibrio-specific viruses. Beyond shedding
light broadly on the function of transposons in Vibrio, this proposal will expand our understanding of how MGEs
promote rapid turnover of defense systems within bacterial populations as part of the pan-immune system. This
topic is of increasingly critical importance, given the spread of antibiotic resistance genes and renewed interest
in phage therapy for V. cholerae and numerous other pathogenic microorganisms.

Public health relevance
PROJECT NARRATIVE The severity of cholera epidemics is affected by dynamic oscillations in the abundance of pathogenic Vibrio cholerae strains and the bacterial viruses that infect them. We recently discovered a class of CRISPR-associated transposons in V. cholerae that encode diverse antiviral defense systems, suggesting a possible function in enhancing microbial fitness and pathogenicity by spreading innate immunity. The proposed project aims to comprehensively explore the evolutionary diversity of CRISPR-transposons, investigate how cargo genes impact phage predation, and develop novel genome engineering tools in Vibrio cholerae for large-scale genomic insertions and deletions.